RNA regulatory circuits in allergic airway inflammation

PROJECT SUMMARY/ABSTRACT
Asthma is a chronic inflammatory airway condition with high global prevalence causing significant morbidity and
mortality. Allergic, “type 2” (T2), inflammation is the defining feature of asthma in many patients. Type 2 T helper
(Th2) cells and the airway epithelium, acting through the canonical T2 cytokines IL-4 and IL-13, have central
roles in asthma. Polarization of T cells towards a Th2 phenotype via IL-4 stimulation creates a pool of Th2 cells
that are a major source of IL-13 in the airways. Sustained airway epithelial exposure to IL-13 causes goblet cell
metaplasia and stimulates the secretion of chemokines that recruit inflammatory cells to the lung. When left
unchecked, these changes amplify over time, increasing disease severity and promoting exacerbations that carry
high morbidity and mortality. The mechanisms that control the magnitude and duration of T2 signaling in asthma
are not well understood. In this proposal, we seek to identify RNA regulatory circuits that drive persistent
T2 inflammation in T cells and the airway epithelium. Post-transcriptional regulation is an important
mechanism that allows cells to tune the intensity of inflammatory responses. Interactions between 3’ untranslated
regions (UTRs) on mRNAs and RNA binding proteins (RBPs) are key to this regulatory level. RNA binding
proteins interact with the 3’ UTRs, dictating transcript stability, degradation, and localization. These circuits give
cells dynamic control over the flow of transcriptomic information into cellular actions. Post-transcriptional
regulation is understudied in asthma and presents the potential to define novel mediators of T2 inflammation.
Our lab recently identified the STAT6 3’ UTR as a potentially important post-transcriptional regulatory element
in T2 high asthma. Signal transducer and activator of transcription 6 (STAT6) is a critical mediator of T2 gene
expression programming, acting as a transcription factor in response to IL-4 and IL-13. The STAT6 3’ UTR has
multiple regions with protein occupancy and contains a SNP (rs1059513) that is highly associated with asthma
and allergy, suggesting regulatory control that may dictate sensitivity to IL-4 and IL-13. Through high resolution
mapping, we seek to identify functional elements across the STAT6 3’ UTR and their role in regulating the T2
signaling intensity in T cells and the airway epithelium. We will assess how these functional elements control
gene expression, cytokine secretion, and epithelial cell differentiation. We have also identified candidate RBP
regulators of T2 inflammation in the airway epithelium which include IGF2BP3, ZFP36L1, and ZFP36L2. Using
CRISPR activation and interference, we will evaluate how these proteins control IL-13 mediated gene
expression, pathologic mucus accumulation, and airway epithelial cell differentiation. These studies will
illuminate clinically relevant post-transcriptional circuits in asthma and nominate novel pathways for potential
therapeutic targeting. This project will be completed through a postdoctoral fellowship at UCSF and will utilize
comprehensive institutional support and resources to prepare the applicant for an independent research career.

Public health relevance
PROJECT NARRATIVE Asthma is an obstructive airway disease frequently driven by unrestrained allergic, “type 2” (T2), inflammation. The regulatory mechanisms that control the magnitude and duration of inflammatory responses in asthma are not well characterized. This proposal seeks to determine how post-transcriptional circuitry involving mRNA and RNA binding proteins tunes the intensity T2 inflammatory signaling in asthma, with the goal of revealing novel pathways that may have potential for therapeutic targeting.